TOPOLOGICAL MECHANISMS OF DNA BREAK REPAIR IN LYMPHOCYTES

Summary
Mammalian genomes are subject to a constant barrage of damage from metabolites, external agents, or
physiologic processes, including transcription and replication. Developing lymphocytes also target double-
strand breaks (DSBs) to antigen receptor loci during V(D)J recombination. To maintain genomic stability, DSBs
must be repaired with high fidelity, minimizing oncogenic alterations such as chromosomal deletions and
translocations. The DSB response extensively revises flanking chromatin via ATM-mediated phosphorylation of
the histone variant H2Ax, producing γH2Ax, which spreads for 100s of kb around a DSB. In somatic cells, most
of which are non-cycling, γH2Ax domains serve as chromatin-based platforms to facilitate repair by the non-
homologous end joining (NHEJ) and, likely, as adherent surfaces to hold broken chromosome ends together.
Indeed, ends are destabilized in cells lacking ATM or H2Ax, which have elevated levels of translocations.
Thus, a deeper understanding of mechanisms that coordinate DSB repair and sequester ends from the rest of
the genome remains an important goal. In this regard, links between repair, transcription, and epigenetic
landscapes around DSBs are emerging. A feature that bridges many of these processes is the 3D
conformation of chromatin, which determines the range of chromosomal contacts made by a persistent DSB.
The applicant has shown that the topological “environment” of a DSB in non-cycling lymphocytes determines
the spread and contours of γH2Ax domains, paralleling chromosome contacts of the break site. In addition,
transcription of genes within γH2Ax domains was repressed, perhaps minimizing introduction of new breaks
associated with RNA polymerase readthrough. A key finding from the prior funding period was that DSBs near
the border of topologically-associated domains (TADs) produce highly asymmetric γH2Ax platforms on each
chromosome end – one of which is very short – which may enhance disassociation of chromosome ends when
the break persists. Indeed, genomic alterations, including those associated with cancer, are enriched near
topological borders. Launching from these discoveries, the applicant now proposes to define the functional
relationships between chromosome topology and DSB repair outcomes. Overarching hypotheses for three
aims of the project are: (i) persistent DSBs adjacent to TAD borders will generate distinct profiles of repair
products due to unstable association of chromosome ends, promoting extensive deletions and translocations,
(ii) the mechanism of TAD formation, called loop extrusion, is required for generation of DDR platforms;
impairment of this process will deleteriously affect repair outcomes, and (iii) transcription within a γH2Ax
domain harboring a persistent DSB will enhance the probability of its deletional repair to an expressed gene
with which it contacts. Together, the proposed project will fill fundamental knowledge gaps about how DSB
responses integrate spatial, transcriptional, and chromatin-based mechanisms to sequester chromosome ends
for efficient repair, minimizing their oncogenic potential in somatic cells.

Public health relevance
Narrative Damage to our genome, including DNA double-strand breaks programmed in developing lymphocytes, must be recognized and efficiently repaired to avoid oncogenic aberrations, such as chromosomal translocations. The DNA break response includes extensive revisions of regional chromatin; however, the impact of spatial architecture surrounding damage sites on their subsequent repair remains unknown. This project will define how the three-dimensional conformation of our genome can aid or impede the holding together of broken chromosome ends until they are repaired, thus impacting their potential to produce cancer-causing alterations.